Administrative Core

PROJECT SUMMARY (Administrative Core)
Achieving an integrated learning health system (LHS) requires leadership and an administrative infrastructure
to cultivate learning communities to share knowledge, recruit and retain new LHS scientists, promote
community engagement, and to facilitate communication across partner institutions. Expanding on existing
infrastructure and partnerships established at the University of Minnesota (UMN) under the Minnesota
Learning Health System K12 Mentored Career Development Program (MN-LHS) and its Center for Learning
Health System Sciences (MN-CLHSS) and framed by the values of service leadership and shared governance,
the Learning Health System Embedded Scientist Training and Research (LHS E-STaR) of the North (LEaRN)
Center Administrative Core (AC) will provide leadership and administrative oversight of the LEaRN Center to
ensure 1) an equitable governance, administrative and communications infrastructure; 2) coordinated research
and educational support; 3) innovative patient-centered outcomes and comparative effectiveness research
(PCOR/CER) conducted in learning health systems; 4) innovative programming and support that connects
trainees, researchers, community stakeholders, and policy makers in knowledge sharing and application for
change; and 5) a rigorous system for program evaluation and improvement that will ensure Center impact.
The LEaRN Center AC Leadership Team, composed of senior faculty members from each core institution
(UMN, M Health Fairview, M Health Fairview, the Minneapolis VA Health Care System Essentia Health,
HealthPartners, and Hennepin Healthcare), will serve under multiple PIs (MPIs) Drs. Timothy Beebe and
Genevieve Melton-Meaux. Other members of the leadership team will include the co-directors of the Research
Education Core and the Research Data Analysis Core. Notably, the LEaRN AC leadership team has an
established history of research collaboration and of providing diverse educational and experiential research
and training opportunities to scientists to equip them with the tools and expertise to seamlessly transition to a
fully embedded LHS scientist.. The site PIs from the hub partner sites will join the LEaRN AC leadership team
in biweekly meetings to promote synergy and integration across institutions to strengthen the academic reach
and alignment and impact of LEaRN activities across Minnesota. Overall, the LEaRN AC leadership team will
oversee and manage all aspects of the LEaRN Center and the related finances and coordinate all
administrative aspects of the Center as well as new initiatives, scholar progress, mentor effectiveness, and
program outcomes. The LEaRN AC will also coordinate all internal and external communications, manage all
LHS scientist recruitment and retention processes, oversee supportive or corrective actions germane to LHS
scientist and mentor performance, and establish and maintain effective interactions with the UMN Clinical and
Translational Science Institute, the UMN Building Interdisciplinary Research Careers in Women's Health
program, and other key institutional educational and research infrastructures.